Research Supplements to Promote Diversity in Health-Related Research

ABSTRACT: Surgical tumor resection depends on the ability to distinguish tumor from normal tissue
parenchymal. This determination is frequently made in real-time by the surgeon using direct visualization,
mechanical and tissue handling properties at the time of resection, intraoperative pathology analysis and other
intraoperative imaging methods. Extensive training and assistive intraoperative imaging devices allow the
surgeon to remove the unhealthy tissue, and subsequent confirmation, classification and grading is often
performed over the subsequent days to weeks through standard histopathologic, immunohistologic, and
microscopic methods. This delay in the confirmation process (often taking up to a week or more to complete the
following resection and in most instances not complete by the conclusion of the operation) can impact the timing
of adjuvant treatments pending these critical data which guides subsequent clinical decisions for the patient.
It is precisely this gap in treatment that we hope to explore. Both the Brain Tool Laboratory and Duke
University Hospital have and support an infrastructure for researchers to tackle complicated and critical problems
in healthcare. First, and more basically, we aim to evaluate the ability of a noncontact endogenous fluorescence
excitation and emission device to classify tissue pre- and post-ablation. These findings would assuredly lend
themselves to research conducted for laser interventions in surgery. But more fundamental is our aim to
investigate whether the use of such device can improve the surgeon’s and pathologist’s ability to successfully
classify tumor. Our system is designed to use endogenous fluorescence to interpret metabolic biomarkers of
tumors and parenchyma on surgical explanted tissues to assist surgeons and pathologists in making an accurate
diagnosis. Upon successful classification based on excitation and emission spectra, we further aim to create a
technology of machine learning algorithms that distinguishes first between normal versus tumorous tissue and
second among tissue subtypes.
Contact-dependent methods have been pursued and studied in the past, especially successful in small
animal models. However, our proposed noncontact method has not yet been investigated in the operating room.
A surgeon’s decision to pursue a margin or lesion more aggressively depends on having the most accurate and
accessible information available. By offering just that, we hope to tackle this need for an intraoperative detection
device that determines not only the tumor margin but real-time pathological identification and classification. To
this end, we will conduct the following Specific Aims:
Aim 1: Investigate whether the use of a non-contact endogenous fluorescence excitation and emission device
improves the surgeon’s and pathologist’s ability to successfully classify tumor.
Aim 2: Evaluate the device’s ability to classify tissue pre- and post-ablation to expand its applicability in the
TumorCNC.

Public health relevance
Project Narrative The proposed research will focus on implementing a new technology in neurosurgery: a novel laser identification device that assesses whether tissue is parenchymal or tumor. Because surgeons face difficulty in assessing tissue intraoperatively (limiting ability to visualize margins for resection), this research acts on an imperative for a real-time point of care diagnostic device.